Use of High Density Lipoprotein Proteome in the Prediction of Cognitive Impairment and Alzheimer's Disease: (REGARDS)

PROJECT SUMMARY
Alzheimer’s disease (AD) is a progressive neurodegenerative disorder that afflicts 5.1 million Americans aged
65 or older. Chronic inflammation is a central feature of the pathology present in AD-affected brains.
Inflammatory responses to neurodegeneration increase production of reactive oxygen species, and expression
of cytokines, adhesion molecules, complement proteins, and degradative proteins, cellular activation of
microglia and astrocytes, and production of beta amyloid. Complement C1q is necessary for amyloid-B
synaptoxicity in murine models. In the cerebrospinal fluid of individuals diagnosed with normal cognitive
function, mild cognitive impairment and AD, APOE4 genotype was associated with cerebrospinal fluid
complement 3, amyloid – beta and hyperphosphorylated tau (ptau). The association between C3 and tau was
significant only after adjustment for amyloid. These data suggest that the complement cascade and APOE4
results in elevated AD neurodegeneration and that amyloid regulates the effect of the complement cascade on
downstream tau pathology. Emerging evidence from genetic, clinical and experimental studies support the
involvement of high-density lipoprotein (HDL) constituents in inflammation, cognitive function and progression
to AD. Cognitive impairment (CI) has been associated with lower levels of the HDL proteins apoA-I, apoA-II
and apoH and higher levels of apoE and apoJ (clusterin). More than 20 loci associated with HDL metabolism
contribute to the risk of AD including variants in clusterin. This study is designed to determine the association
between (1) the high-density lipoprotein (HDL) proteome and (2) single nucleotide polymorphisms (SNPs)
related with HDL and inflammatory proteins with CI and AD in African-American and white adults. This study
will be conducted from a genome wide association study of validated cases of AD in REasons for Geographic
and Racial Differences in Stroke (REGARDS) study participants.

Public health relevance
PROJECT NARRATIVE This research aims to determine the association between (1) the high-density lipoprotein (HDL) proteome and (2) single nucleotide polymorphisms (SNPs) related with HDL and inflammatory proteins with CI and AD in African-American and white adults. This study will be conducted from a genome wide association study of validated cases of AD in REasons for Geographic and Racial Differences in Stroke (REGARDS) study participants.